MutSensor System: A Set of Highly Sensitive Mutation Reporters to Dissect Genome Stability in Health and Disease

Summary
Our cells are constantly exposed to mutagens that cause DNA damage, which if left unrepaired, cause mutations.
At the cellular level, the progressive accumulation of mutations in somatic tissues drives carcinogenesis and
other diseases. Despite significant advances in our understanding of mutational processes, the answer to many
fundamental questions is still a mystery. What are the genetic causes of mutations in human tissues? How
do different cell types in the human body control DNA damage and repair? Despite our large body of
knowledge in the pathways that control DNA damage and repair in model organisms, we lack a deep
understanding of this process in human tissues. This would be critical to understand how mutations lead to
human diseases including carcinogenesis.
Here we will use a highly innovative approach to build MutSensor, a set of mutation reporters to estimate
DNA mutation frequency in mammalian cells with a sensitivity >50-fold higher than that of existing
methods. The ability to build and precision deliver these MutSensors is enabled by “Genetic Writing and
Delivery” system developed in the Boeke lab. This novel method will allow large-scale functional genetic
screening at an unprecedented scale. Building on our preliminary data, we aim at comprehensively identify all
genes that regulate mutation frequency in different human cell types. To this purpose, we will utilize loss- and
gain-of-function screening libraries to determine the effect of genetic perturbations on mutation frequency across
cell types.
These studies will provide an unprecedented systematic map of genes and pathways controlling DNA damage
and mutations across different human cell types. In addition, our novel methodology will represent an important
asset for the scientific community that can have several biomedical applications in a variety of fields
providing an easy tool to study genetic factors that control mutagenesis in health and disease states,
including (but not limited to) carcinogenesis.

Public health relevance
Project Narrative The progressive accumulation of DNA mutations in somatic tissues drives cancer and other diseases; despite significant advances in our understanding of mutational processes, the answer to many fundamental questions in the field of genome integrity is still a mystery. In this project, the first goal is to develop a novel functional ‘reporter’ to estimate DNA mutation rates in mammalian cells with a sensitivity >50 fold compared to current methods. The second major goal of this project will be to study mutation rate in several types of human cells and comprehensively identify all genes that regulate mutation rates across cell types.